Defining Inflammatory Triggers that Induce Diverse Subtypes of Gastric Metaplasia

PROJECT SUMMARY
Chronic gastritis initiates a pathological progression of disease which in some individuals culminates in
gastric cancer, the fourth leading cause of cancer related mortality worldwide. Helicobacter pylori infection is the
most common cause of gastritis and responsible for most gastric cancer cases worldwide. Autoimmune gastritis
is another prominent cause of gastritis increasing the risk of gastric cancer development. Persistent gastric
inflammation initiates the transformation of healthy epithelial cells into pre-cancerous metaplastic cells which
transform into adenocarcinoma in a subset of individuals. Recent transcriptomic analyses of gastric
adenocarcinoma have led to the identification of four distinct molecular subtypes. This discovery has improved
targeted treatment and surveillance strategies for each distinct gastric cancer subtype. Currently, there is a need
for an in-depth molecular analysis of pre-cancerous gastric metaplasia. We recently discovered that gastric
metaplasia can also take on distinct molecular phenotypes in the autoimmune setting. It needs to be determined
whether metaplasia arising out of H. pylori infection, known to inject cytotoxins that can interfere with cell-
signaling pathways possibly promoting oncogenic transformation, is phenotypically distinct from metaplasia
arising out of autoimmune gastritis. If metaplastic subtypes are conserved, then chronic inflammatory signals,
independent of etiology, likely contribute to cancer progression; however, if metaplastic subtypes in infection are
distinct from autoimmunity, then factors unique to the bacterial infection likely drive an alternative trajectory of
oncogenic transformation. Furthermore, how certain inflammatory cytokines (e.g., IL-4/IL-13) impact the
development of gastric metaplasia and specific molecular subtypes of metaplasia needs to be established.
Identifying molecular phenotypes of pre-cancerous metaplastic cells, in distinct disease settings, that may carry
differential oncogenic potentials, will contribute to the discovery of novel screening targets to decrease the gastric
cancer burden in highly susceptible individuals. Identifying the inflammatory signals that promote the
development of potentially high-risk metaplastic cells will aid in discovery of new therapeutic strategies for
inhibiting gastric cancer.
In this proposal, metaplasia arising out of two common etiologies of gastritis, H. pylori infection and
autoimmune gastritis, will be molecularly defined and compared. Gastric metaplasia from human gastritis
patients will be transcriptionally profiled to determine the phenotypes of metaplasia induced by human disease.
The impact of inflammatory cytokines, IL-4 and IL-13, on inducing/expanding phenotypically distinct subtypes of
gastric metaplasia will also be determined. This work will improve the mechanistic understanding of gastric
carcinogenesis in the settings of H. pylori infection and autoimmune gastritis. This knowledge can then be used
to improve medical prevention strategies and identify novel targets for therapeutic intervention of gastric cancer.

Public health relevance
PROJECT NARRATIVE Gastric cancer is a major cause of cancer related death worldwide and screening practices are not routine in the US, leading to late diagnosis and poor outcomes. To improve accurate diagnoses and medical intervention, different types of metaplasia need to be molecularly defined and the inflammatory signals that trigger development of potentially high-risk metaplastic cells need to be established. The proposed research aims to define types of metaplasia that 1. Arise in models of Helicobacter pylori (Hp) infection compared to models of autoimmune gastritis (AIG), 2. Arise in human Hp compared to AIG patients, and 3. Are selectively induced/expanded by inflammatory cytokines, to ultimately improve methods in gastric cancer early detection and prevention.